Evaluating the effect of water fluoridation on adverse birth outcomes

Project Summary/Abstract
The objective of this K99/R00 proposal is to estimate the effect of community water fluoridation on adverse
birth outcomes in California and identify whether there are subpopulations who are especially vulnerable to
fluoride exposure during pregnancy. Fluoride has been added to water supplies to promote dental health in the
United States since 1945, but the impacts on pregnancy outcomes have never been assessed.
It is possible that maternal and in-utero fetal exposure to fluoride increases risk of preterm birth and small-for-
gestational age. A small number of studies in other countries suggest there is an increased risk of adverse
birth outcomes associated with drinking water with naturally high levels of fluoride, and evidence suggests
fluoride consumption can affect thyroid function and cardiovascular systems, both of which play important roles
in regulating and maintaining a healthy pregnancy. Since 1995, California has required water systems with at
least 10,000 service connections to fluoridate their water, but systems were only required to implement a
fluoridation program once the funds were allocated. Therefore, there is a substantial amount of variability in
which water systems have added fluoride over the last 25 years, and when they did so.
We will leverage this variation in water fluoridation practices in California to (1) identify the effects of changes
in water fluoridation on adverse birth outcomes during 2006-2017 and (2) evaluate whether there are
heterogeneous exposure effects by maternal/fetal characteristics and environmental co-exposures.
Furthermore, we will use the ECHO.CA.IL pregnancy cohort, which is composed of pregnant women and their
children in San Francisco and Illinois, to (3a) assess whether maternal urinary fluoride during the second
trimester is associated with reduced gestational age or lower birthweight-for-gestational-age-z-scores at birth
and (3b) evaluate whether there are heterogeneous effects of exposure by maternal/fetal characteristics and
environmental co-exposures.
The research plan is bolstered by an exceptional mentorship team and training plan at the University of San
Francisco, California. The proposed project builds on the applicant’s background in perinatal epidemiology and
provides training in new statistical methods to identify heterogeneous exposure effects and education in the
biological processes of gestation and parturition, exposure assessment of environmental chemicals, and
translating scientific findings to policymakers. The combined research and training plans will enable the
candidate to transition into an independent researcher of policy-relevant social and environmental factors that
shape perinatal health.
This research aligns with NIEHS’s strategic goals to evaluate health effects of the exposome, identify individual
susceptibilities to environmental hazards, utilize data science techniques, and generate evidence that can be
utilized by policymakers to improve population health.

Public health relevance
Project Narrative Community water fluoridation may affect perinatal health outcomes, but this has never been evaluated in the United States. It is critical to understand how this widespread practice affects the health of mothers and infants, and whether subgroups of the population are uniquely vulnerable. This project will provide critical information to assist public health officials in making informed decisions about the ongoing practice of adding fluoride to water supplies in the United States.